Harnessing divergent reactivities of unusual reactive intermediates as platforms to explore high Fsp3 amine chemical space

Project Summary/Abstract:
Efficient access to molecules of importance to human health has long driven the development of innovative
synthetic methods. In recent years, greater emphasis has been placed on exploring stereochemically complex
molecular space with high Fsp3 that is not well-represented in typical compound screening libraries. In this
context, N-heterocycles and aminated carbocycles are attractive targets, as they are widely prevalent in drugs,
natural products, biomolecules and ligands. We are developing two modular platforms capable of rapid, flexible
transformations of simple precursors (alkenes, dienes, allenes, imines) into azetidines, pyrrolidines, piperidines
and other N-heterocycles and amine-bearing carbocycles. Mechanistic insights are used to tune the fate of
underexplored reactive intermediates that include methyleneaziridines, aziridinium ylides and 2-amidoallyl
cations. The first platform leverages our expertise in catalyst-controlled nitrene/carbene transfers to furnish
aziridinium ylides that are shuttled along diverse paths to deliver stereochemically rich amines and
enantioenriched N-heterocycles. A second platform explores mild ways to generate 2-amidoallyl cations from
allenes and engage these reactive species in enantioselective cycloadditions for rapid syntheses of densely
functionalized carbo- and heterocycle synthetic building blocks.
In addition to the continued development of synthetic methods to furnish molecules with high Fsp3 linked to
higher success in drug screening libraries, the biological testing of chemical space unlocked by our work is
important to its long-term significance. Several compounds from our libraries show a range of anti-cancer, anti-
TB, antimalarial and other activities, but preparing individual compounds is time-consuming and labor-intensive,
limiting the impact and significance of our work. We are adapting our synthetic methods to the synthesis of DNA-
encoded libraries that will be made available to screening facilities at UW-Madison and more broadly to the
academic and industry communities. Last, our innovative methods for amine synthesis will be applied to natural
product analogs of the anti-malarial compound jogyamycin and the anticancer antibiotic nogalamycin to
understand structure-activity relationships, with a long-term goal of uncovering new small molecule binders of
the ribosome. Jogyamycin and nogalamycin are challenging targets for total synthesis, as molecules that bind
the ribosome often do not follow the Lipinski ‘rule of 5’ due to the highly electronegative surface potential and
limited buried surface area differ from proteins and often contain several contiguous stereocenters bearing polar
hydroxyl and amine groups that are tedious to prepare using current synthetic methods, but are readily
accessible using our synthetic methodologies.

Public health relevance
Proposal Title: Harnessing divergent reactivities of unusual intermediates as platforms to explore high Fsp3 amine chemical space. Project Narrative: Bioactive amine motifs occur in diverse molecules of key importance to human health, but the lack of diversity in current drug libraries has increased interest in high Fsp3 chemical space, defined as the # sp3 C/total # C. This project uses mechanistic insight to tune the reactivities of unusual intermediates (methyleneaziridines, aziridinium ylides, 2-amidoallyl cations) to achieve mild, versatile syntheses of stereochemically rich, densely functionalized N-hetero- and carbocycles, including those in bioactive molecules that bind to specific ribosomal subunits. These modular and unified strategies to build N-heterocycles of varying ring sizes and substitution patterns from a simple pool of precursors is an attractive addition to the synthetic lexicon, given the prevalence of such rings in FDA-approved drugs.